Puberty, diabetes, and the kidneys, when eustress becomes distress

PROJECT SUMMARY / ABSTRACT:
Diabetic kidney disease (DKD) is a common and serious complication in youth with 2 diabetes (T2D).
Epidemiological data implicate puberty as a major accelerator of kidney injury in youth with obesity and
diabetes, yet the mechanisms by which reproductive maturation results in kidney disease remain unknown.
A better understanding of the pubertal mechanisms contributing to kidney disease is needed to promote
preservation of native kidney function, especially in high-risk youth with obesity and/or T2D.
We hypothesize that youth with obesity and/or T2D experience relative kidney hypoxia during puberty due to
a metabolic mismatch between increased renal energy expenditure and impaired substrate metabolism. In
turn, the kidney hypoxia results in loss of glomerular charge and size selectivity with increased
transglomerular transport of protein, and kidney dysfunction. To address these hypotheses, we propose to
design an accelerated longitudinal study in which we will enroll adolescents (8-14 years, 50% girls) with
obesity and elevated hemoglobin A1c (HbA1c ≥6%) [n=60], and healthy normal weight controls [n=40] at
Tanner (pubertal) stages 1-4 and examine them at baseline, 1 and 2-year follow-up. We will combine state-of-
the-art magnetic resonance imaging (MRI) methods for quantifying kidney growth, oxygen availability and
hemodynamic function with gold-standard measurements of glomerular filtration rate (iohexol clearance),
renal plasma flow (p-aminohippurate clearance), glomerular size and charge selectivity (dextran and
IgG/IgG4 clearance) and assessments of insulin sensitivity and mitochondrial function (intravenous glucose
tolerance test and metabolomics). These experiments are designed to define the mechanisms contributing to
kidney injury during puberty and identify novel risk factors and therapeutic targets to mitigate the
development of obesity and diabetes-related nephropathy.

Public health relevance
Project Narrative: Youth-onset type 2 diabetes (T2D) typically manifests during or shortly after puberty and is characterized by a greater frequency and severity of diabetic kidney disease compared to adult-onset T2D and type 1 diabetes of similar duration. Puberty is recognized to accelerate kidney injury in youth with obesity and diabetes and may explain the magnified risk of diabetic kidney disease in youth-onset T2D, yet the pubertal mechanisms contributing to kidney injury in obesity and youth-onset T2D are unknown. The accelerated longitudinal study proposed in this application seeks to address these substantive gaps in knowledge.